Transcriptome and Network Analysis of Cleft Palate

ABSTRACT
Cleft palate is one of the most common structural birth defects. Surgical correction and medical and psychosocial
care impose significant personal and societal burdens. Increased understanding of the etiology of cleft palate
potentially will lead to improvements in diagnosis and treatment. Palatogenesis is enormously complex. Paired
palatal shelves first extend vertically from the maxillary processes and must grow sufficiently so that upon
horizontal elevation their medial edges come into contact. Epithelia covering the medial shelves disintegrate,
allowing their fusion. Key processes involved include epithelial/mesenchymal interactions and transitions.
Studies in humans and mice have identified at least 429 genes associated with oral clefting. Reductionist
scientific approaches have provided detail about individual genes and pathways in palatogenesis, but the intuitive
models generated are not sufficient to represent the enormous complexity of the process. We will employ
transcriptome and network analyses to understand how biological components work together to produce system-
wide outcomes of epithelial differentiation and adhesion, mesenchymal biomechanical properties affecting
remodeling and shelf elevation, and anterior/posterior regionalization of epithelia and mesenchyme. These
processes require the integration of multiple cross-regulating signaling pathways. Fibroblast growth factor (FGF)
and sonic hedgehog (SHH) are two such pathways, and their information is integrated with other pathways by
the transcription factor p63. We will generate bulk and single-cell RNA-seq libraries from the palatal shelves of
wild type mice to discover gene coexpression and regulatory networks, and specific cell populations involved in
normal palatogenesis. For bulk RNA-seq libraries we will separate anterior and posterior epithelial and
mesenchymal compartments allowing region-specific analysis of transcriptional changes. We will use the same
approach for four mutant mouse lines, exploiting these gene perturbations to identify key driver genes and
interacting pathways within these networks. We will study two activating FGFR2 mutations that exert their
differential effects from the epithelium or the mesenchyme (S252W or C342Y) and null mutations of SHH and
p63, expressed in the epithelium. Complementary bulk and single-cell RNA-seq libraries will identify differential
gene expression and novel key components and pathways critical to palatogenesis. We will use these datasets,
in conjunction with publicly available palate-related datasets to build high-resolution, multiscale molecular
networks that will be used to develop predictive, mechanistic models of palatogenesis. Novel molecular networks
and key regulators identified through the multiscale network modeling approach will be validated by in situ
hybridization, immunohistochemistry, palatal organ cultures, and mouse models. Our innovative approach to
generating comprehensive datasets, using advanced systems biology technologies, and building multiscale
network models of normal and abnormal palatogenesis will have a large impact on the clinical, craniofacial,
-omics, and developmental biology fields.

Public health relevance
NARRATIVE Cleft palate is one of the most common birth defects, requiring significant surgical, medical, and psychosocial intervention. Normal palate development is mediated by multiple signaling pathways and hundreds of genes, and their perturbation by genetic or environmental insult leads to cleft palate. This project will apply gene expression and predictive, multiscale network analyses to gain insight into palate development and the involvement of key process such as epithelial/mesenchymal interactions in mouse models of human clefting to ameliorate or prevent abnormal palatogenesis.